Core A: Administrative Core

PROJECT SUMMARY
The Administrative Core is responsible for the overall leadership and management of the Program Project Grant
(P01), and it will provide overall organizational, administrative, and scientific management. The Administrative
Core will oversee and coordinate all P01 components and centrally monitor and evaluate their performance. In
addition, the Administrative Core will facilitate all interactions with the Internal Advisory Board (IAB) and External
Advisory Board (EAB). This P01 application involves 6 institutions and 5 key investigators, as Project and Core
leaders. The Administrative Core will be essential in coordinating all communications and reviewing all activities
among Projects and Cores that will take place across the participating institutions. The Administrative Core will
administer all the subcontracts, work closely with all participating institutions in order to use existing facilities and
build upon those when required, and ensure that best practices for animal studies and human subjects research
are met and monitored appropriately. It will additionally ensure that access to all scientific core facility services
are managed to ensure that the overall goals of the P01 are met. The Administrative Core personnel will be led
by Dr. Lathia, with collaboration from Drs. Barnholtz-Sloan and Waite and Ms. Schiciano. Both Drs. Lathia and
Barnholtz-Sloan have extensive experience in managing multi-institution programs. The proposed P01 team has
a successful record of accomplishment of working together on multiple collaborative efforts. The Specific Aims
are:1) To provide all organizational, administrative, and scientific leadership for the P01 Projects and Cores by
cultivating and promoting the P01 team through innovation and excellence, leveraging resources, and providing
constructive feedback; 2) To provide administrative management for all fiscal management of the P01 including
but not limited to accounting of grant funds, progress reports, communication, meeting scheduling and minutes,
and manuscript and grant preparation; 3) To evaluate research progress through oral and written documentation,
with regular input from the IAB, EAB, and National Cancer Institute (NCI) leadership in order to ensure that each
project is meeting its objectives within the proposed time frame; 4) To ensure and monitor best practices for
human subjects and animal research for all P01 Projects and Cores; data operations (in collaboration with the
Biostatistics and Bioinformatics Core); and adequate human and animal biospecimens for all projects (in
collaboration with the Experimental Models Core); and 5) To raise awareness of the P01 through promotion of
seminars, recruitment of postdoctoral fellows, scientific exchanges, coordination of an annual scientific retreat
involving the scientists in the P01, and through training and development plans that will ensure state-of-the-art
practices.